Host cell membrane perforation during invasion by Toxoplasma gondii

Toxoplasma gondii is a widespread protozoan parasite that can cause life-threatening disease in
immunocompromised individuals and the developing fetus. While drugs are available to treat acute
toxoplasmosis, they are frequently discontinued due to severe adverse effects. The development of new, better-
tolerated drugs requires an improved understanding of the biology of T. gondii and the mechanisms underlying
its virulence so that critical points of vulnerability in its life cycle can be identified and targeted.
T. gondii belongs to a group of related human pathogens, the Apicomplexa, which also includes the causative
agents of malaria (Plasmodium) and cryptosporidiosis (Cryptosporidium). Apicomplexan parasites must invade
into cells of their hosts in order to survive and multiply. During the early stages of invasion, proteins are
exocytosed from apical organelles known as the rhoptries. After their release, these proteins are delivered into
the host cell cytosol where they participate in parasite internalization, inactivate host innate immune defenses,
and manipulate host gene expression to the parasite’s advantage. Because the injected effector proteins play
such critical roles in parasite invasion and intracellular survival, they are among the most important of the
parasite’s virulence factors. While we know a great deal about the functions of these effector proteins, we know
virtually nothing about the process by which they are delivered into the host cell. The goal of this project is to fill
in this important gap in our understanding of host cell invasion by apicomplexan parasites.
We have previously shown that when T. gondii first contacts a host cell, it causes a transient (~200msec)
disruption in the barrier integrity of the host cell plasma membrane. The central hypothesis of this project is that
this transient perforation of the host cell membrane, which we can detect using high-speed multiwavelength
fluorescence microscopy, serves as the conduit through which rhoptry proteins are injected into the host cell.
The major Aims of the project are to: (1) Determine the physical nature and proximate cause of host cell
perforation during invasion and (2) Determine how the perforating agent is delivered to the host cell membrane
and the function of the breach it creates.
How rhoptry proteins are injected into the host cell during invasion is a fascinating cell biological problem,
and current evidence suggests that the underlying mechanisms are novel. A greater understanding of these
mechanisms may lead to new approaches to treating or preventing toxoplasmosis, since targeting the injection
process will simultaneously disrupt the delivery into the host cell of many of the parasite’s most critical virulence
factors. In addition, because rhoptry protein injection into the host cell occurs in all apicomplexans examined,
the results of this project are likely to be directly applicable to related human pathogens such as Plasmodium
and Cryptosporidium.

Public health relevance
Toxoplasma gondii is a widespread human pathogen that can cause life-threatening infection in the developing fetus and in people who are immunocompromised due to AIDS, chemotherapy or organ transplantation. This project will increase our understanding of how the parasite delivers proteins that are important to its ability to cause disease into the cells of its host during infection. A better understanding of this process will provide new opportunities for the development of drugs to treat the devastating disease caused by these parasites.